Early to Late Events in Colorectal Neoplasia: Basic Biology to Clinical Implementation

PROJECT SUMMARY/ABSTRACT
The focus of this renewal remains colorectal cancer (CRC), the 2nd leading cause of cancer mortality worldwide.
During the last cycle of funding, seminal advances were made related to early and late events in colorectal
neoplasia, utilizing cutting-edge technologies and uncovering paradigm-shifting concepts applicable to other
solid tumors. In the next cycle, we will concentrate on microsatellite stable (MSS) CRC, which accounts for 85%
of CRC and does not respond to immune checkpoint blockade (ICB) in marked contrast to microsatellite unstable
(MSI-H) CRC. As MSS tumors are derived from a stem/progenitor epithelial cell population, we propose studies
involving the identification of a novel marker for a quiescent stem cell population, Tob2, as well as determining
the nonredundant roles of Lrig1 and Lrig3 in colonic tumor formation as they are critical regulators of intestinal
homeostasis. In separate studies using a novel NSC-seq platform, we have identified Tob2 that is expressed
early in mouse embryogenesis and marks a population of quiescent stem cells that will be probed for its ability
to impact colonic tumor formation as well. Also, we have discovered a 4-gene immune-exclusion (IEX) score in
MSS CRC that impacts clinical outcome. Three of the genes encode secreted proteins (DDR1, TGFBi, DPEP1)
that may be responsible for IEX and are therapeutically tractable. A clinical trial has already started combining a
neutralizing antibody to DDR1 and ICB. A major area of investigation has been small extracellular vesicles (sEVs)
and an amembranous nanoparticle, termed supermeres, which we recently discovered. Remarkably, DPEP1
and TGFBi are the two most abundant proteins in CRC sEVs and supermeres, respectively; DDR1 is also
enriched in supermeres. Of note, these proteins are markedly increased in the respective plasma-derived
fractions of CRC patients versus healthy controls so they may serve as CRC biomarkers. We propose
mechanistic studies to determine the function of these proteins, including that of a novel isoform of DPEP1 whose
overexpression results in tumor formation in mice. Our discovery of supermeres has opened the possibility for
new biomarkers and ways to target tumor progression through cell-cell communication, which we will explore
through understanding supermere biogenesis and determining supermere function in immunomodulation of the
CRC tumor microenvironment. In this renewal, we intend to continue to make paradigm-shifting discoveries that
impact the ways of thinking about cancer, its origins, how it progresses, as well as implementing practice-
changing strategies to diagnose and treat MSS CRC.

Public health relevance
At least 85% of colorectal cancer (CRC), the 2nd most frequent cause of cancer deaths worldwide, is due to microsatellite stable (MSS) CRC, which does not respond to immune checkpoint blockade (ICB), in contrast to microsatellite unstable (MSI-H), in which durable remissions are achieved with ICB. By combing single-cell RNA- sequencing (scRNA-seq), regional whole exome sequencing (WES), spatial transcriptomics (ST) and MxIF to enumerate consensus cell states and to project tumor programs and microenvironmental features onto progression pseudotime, we have identified an immune-exclusion IEX score in MSS CRC that consists of DDR1, TGFBi and DPEP1, which are markedly upregulated in plasma-derived small extracellullar vesicles (sEVs) and supermeres of CRC patients compared to healthy controls, and for which inhibitors are developed or being developed. In this R35 renewal, we propose to explore mechanisms by which these proteins promote tumorigenesis, develop them as liquid biomarkers, and introduce novel strategies to introduce inhibitors to them in the clinic.